Long-term sequelae of intimate partner violence identified in hospital settings in New York State: a network analysis approach

PROJECT ABSTRACT
Many survivors of intimate partner violence (IPV) continue to suffer consequences even after the abuse has
ended, with a constellation of long-term health problems that are poorly understood and may be mis-
diagnosed, delaying needed treatment. Advanced methodological approaches are needed that can help to
identify individuals exposed to IPV who may be at greatest risk for long-term adverse outcomes. We propose
to apply network analysis methods to characterize the structure of diagnoses at index IPV-related hospital
visits and examine how features of these network structures predict longer-term outcomes, including mortality.
Our central hypothesis is that understanding the strength and patterns of connections between comorbidities at
these index visits will shed light on longer-term trajectories, including repeat IPV visits and death. We will test
this hypothesis by pursuing three specific aims: (1) Identify networks of comorbid diagnoses that characterize
index IPV-related emergency department (ED) visits and hospitalizations, compared to visits among matched
controls; (2) Characterize long-term sequelae across features of index IPV diagnosis networks, compared to
diagnosis networks among matched controls; and (3) Evaluate community-, hospital-, and individual-level
characteristics as potential moderators of relations between features of index diagnosis networks and long-
term sequelae. To achieve these aims, we will conduct a retrospective cohort study using data from the
Statewide Planning and Research Cooperative System (SPARCS), which includes information on all inpatient,
ED, and hospital outpatient clinic visits in New York State, linked to mortality records. Social network analysis
and machine learning methods will be used to characterize IPV-related diagnosis networks and identify the key
features of index diagnosis networks that predict more severe long-term outcomes. We will also use multi-level
analyses to examine the potential buffering effects of hospital- and community-level characteristics. Our
approach is innovative because it applies network analysis approaches to not only characterize baseline
diagnosis networks but to connect them to subsequent outcomes. Our project is significant because it
addresses the under-explored but potentially devastating consequences of IPV and may uncover key red flags
at index visits that could be used to identify individuals at greatest risk for adverse outcomes, prompting
additional screening and safety planning. Our findings will serve as preliminary data for an R01 proposal to
scale-up these methods for a nationwide examination of the long-term sequelae of IPV, including additional
applications of systems science approaches to inform the development of interventions for the prevention of
long-term health effects in this understudied, high-risk population.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because analyzing patterns of comorbidities at index intimate partner violence (IPV) hospital visits may provide important insights into longer-term trajectories of health outcomes among IPV-exposed women and men, including subsequent IPV and mortality. The proposed network analysis approach uses basic administrative data available at a single healthcare encounter to predict future risk and can easily be scaled up and/or transported to other healthcare settings.